Synthesis and non-chromatographic purification of long RNA oligonucleotides containing naturally occurring modification

Title: Chemical synthesis and non-chromatographic purification of long RNA oligonucleotides containing
naturally occurring modifications.
ABSTRACT:
Solid phase synthesis of RNA is an important genomic tool, which offers precise control over the
oligonucleotide sequence and offers an opportunity for site-specific incorporation of RNA modifications,
fluorescent labels and biochemical tags. Discoveries of the twenty-first century created a strong need for a robust
synthesis of RNA strands, that are 100-200 nucleotides (-nt) in length. A major limitation of otherwise highly
optimized process is purification, which is notoriously difficult, labor intensive and requires expensive HPLC
instrumentation. As the result, solid phase synthesis of long oligonucleotides containing RNA modifications is
rarely attempted. This technology-development proposal aims to address this limitation by developing a non-
chromatographic RNA purification method which will be 10-times faster and 2-orders of magnitude cheaper and
will allow isolation of strands that are 100-200-nt long in good yield and 98% purity.
The proposed purification strategy is based on bio-orthogonal inverse electron demand Diels-Alder (IEDDA)
chemistry between trans-cyclooctene (TCO) and tetrazine (Tz) that allows to selectively tag and purify
structurally complex and increasing long RNA strands from the failure strands that accrue during solid phase
synthesis. TCO and Tz are highly selective for each other and have minimal cross-reactivity with other functional
groups found in RNA. The bio-orthogonal click chemistry is highly efficient, even at very low concentrations of
TCO and Tz. During preliminary studies we have shown that our strategy allows efficient synthesis and
purification of 76-nt long tRNA and 101-nt long sgRNA with yields that were 10-times higher than conventional
purification methods.
During the proposed research program, we aim to improve a number of important elements of our design to
bring the overall process to under 7 hrs, further improve the overall yield and purity of the isolated RNA. In Aim
1, we propose to expedite the process by developing a new photolabile linker that will allow fast photocleavage
using visible light. To improve purity and yield of isolated RNA, we propose to optimize the solid phase synthesis
procedure to ensure that all failure sequences are fully capped during each synthetic cycle. The optimized
process will be applied to increasingly longer RNA strands, from 76-nt tRNA to 188-nt long U2 snRNA. In Aim 2,
we plan to illustrate the power of our technology by synthesizing a 144-nt long artificial mRNA, containing m1A
and m6A modifications near the start codon. This will be the longest reported oligonucleotide containing RNA
modifications. The artificial mRNA will be utilized to investigate the impact of RNA modifications on the rate of in
vitro translation. We plan to work with NHGRI technology development team to make the proposed technology
widely available to researchers.

Public health relevance
Public Health Significance In the proposed research, we will develop a new chemical method for synthesis and purification of long RNA oligonucleotides that will be 10-times faster and two-orders of magnitude cheaper than the conventional methods. Chemical synthesis of long oligonucleotides will allow site-specific incorporation of RNA modifications and will allow to investigate their roles in various genetic diseases.